Assessment of Treatment Variability for Pelvic Ring Fragility Fractures (Pelvis ATV)

SUMMARY
Fragility fractures of the pelvic ring are a common injury that is increasing in incidence with an aging population.
These injuries are associated with high healthcare costs and poor patient outcomes, including decline in
ambulatory function, decreased independence, and a one-year mortality of 11-27%. Historically, older adults with
fragility fractures of the pelvis received nonoperative treatment with supportive care because operative
management was deemed too invasive for this patient population. However, the development of percutaneous
and less invasive surgical techniques has led to an increased frequency of operative stabilization of pelvis
fractures in older adults. It is unclear if the increasing use of surgical fixation is improving outcomes for patients
with pelvic fragility fractures. There are significant limitations with the current body of evidence that precludes its
ability to guide clinical practice. Randomized controlled trials testing the efficacy of operative management are
urgently needed to determine when surgical fixation is warranted.
Two pilot randomized controlled trials have been performed on this patient population, and both have not
progressed to a definitive study citing a lack of recruitment feasibility. This is due to both the lack of agreement
amongst surgeons for which patients should receive randomized treatment, as well as a lack of patient
willingness to enroll in a trial. Furthermore, loss to follow up is a concern in both the orthopaedic trauma
population and in older adult study patients. This prospective cohort study will evaluate 120 patients from six
hospitals to determine the feasibility of a randomized controlled trial (RCT) comparing operative versus
nonoperative management of fragility fractures of the pelvic ring. This will be accomplished by three aims
evaluating patient willingness to enroll in a trial, surgeon willingness to randomize their patients’ treatment, and
the completeness of data collection for the proposed patient-important outcomes. A traffic light criteria will use
predetermined progression criteria to evaluate feasibility and guide potential actions to address barriers to a
randomized clinical trial.
The results from this study will confirm the methodology and eligibility criteria of a definitive randomized controlled
trial comparing operative and nonoperative treatment in fragility fractures of the pelvic ring. If numerous feasibility
concerns are raised for the RCT that jeopardizes the validity of the trial, the results from this study will be used
to design a large adequately powered cohort study to compare treatments.

Public health relevance
NARRATIVE Fragility fractures of the pelvic ring are a common injury associated with poor patient outcomes and high healthcare costs. Management of these injuries is evolving with increasing frequency of operative stabilization of the pelvic ring, despite a lack of evidence supporting operative versus nonoperative treatment. This multicenter prospective cohort study will evaluate 120 patients to determine the feasibility of a randomized controlled trial comparing operative and nonoperative treatment, by evaluating patient willingness to enroll in a trial, surgeon willingness to randomize their patients’ treatment, and the completeness of data collection for the proposed patient-important outcomes.